TRANSFER OF INHALED ALBUTEROL TO INFANTS BY BREAST FEEDING MOTHERS

The purpose of this study is to measure and evaluate the extent of secretion of inhaled albuterol into breast milk and its clinical effects on nursing infants.